Dynamics of lipid-anchored proteins

It is often assumed that lipid-anchored proteins non-specifically attach to membranes by the hydrophobic lipid-
modified moiety. We propose that it takes more than lipid-modification to productively organize lipid-anchored
proteins on target membranes. We will test this hypothesis using the Ras superfamily of lipid-anchored small
GTPases (laSGs) as model systems. The Ras superfamily consists of the Ras, Rho, Arf and Rab family of
molecular switches that mediate a wide variety of cellular processes controlling cell growth, motility and
trafficking. The structure of these proteins consists of a conserved catalytic domain, a flexible linker, and a lipid
anchor. Little is known about the precise roles of the intrinsically disordered linker region. By contrast, it is well
established that cycling between active GTP-bound and inactive GDP-bound conformational states of the
catalytic domain regulate function. Disruption of this cycle by mutation or genetic defects causes many diseases
including cancer and developmental disorders. The proposed work will lay the foundation for the development
of effective therapies that directly target these proteins. Supported by strong preliminary data, we hypothesize
that monomeric laSGs engage membranes through one of the following mechanisms: (i) Those with a
moderately long (~20aa) flexible linker between the lipid-anchor and the G-domain adopt multiple distinct
orientations with respect to the membrane plane, with the catalytic domain ‘swinging’ and ‘rolling’ on the surface.
(ii) Those with a long flexible linker keep the G-domain distal from the membrane, with the long linker collapsing
on it as spaghetti would on a wall. (iii) Those with a short (and rigid) linker, such as GTP-bound Arf1, engage
membranes in a single orientation with the G-domain able to roll but not swing on the membrane surface. (iv)
The G-domain of dually lipid-anchored laSGs does not reorient. We will test these hypotheses using state-of-
the-art molecular simulations and simulation-guided experiments. In Aim 1 we will define the sequence and
structural determinants of membrane binding and reorientation of laSGs using atomistic molecular dynamics
simulations to map the conformational and energy landscapes of Rheb, RhoA, Rab11A and Arf1, representing
the Ras, Rho, Rab and Arf family proteins, respectively. In Aim 2, we will determine the functional roles of G-
domain membrane engagement and reorientation using mutations and cell signaling assays, confocal imaging,
electron microscopy (EM), and single molecule FRET in native lipid nanodiscs. Aim 3 will assess the impact of
G-domain membrane interaction and reorientation on the druggability of our model systems. The results will
elucidate the principles and structural regions responsible for the dynamic membrane interaction of laSGs and
define the determinants of their membrane reorientation, and potentially open up novel therapeutic opportunities
to treat many intractable diseases.

Public health relevance
Dysregulation of the switching function of GTP hydrolyzing lipid-anchored signaling proteins, particularly those in the Ras superfamily, leads to intractable diseases including cancer, developmental disorders, and lysosomal and celiac diseases. There is need for effective drugs that directly act on these proteins. The proposed work intends to uncover novel therapeutic opportunities for this class of proteins focusing on their dynamics on membrane surfaces.